Understanding how aneuploidy disrupts quiescence in the model eukaryote Saccharomyces cerevisiae

ABSTRACT
Aneuploidy, the state in which cells carry an incorrect number of chromosomes, is a major problem for human
health. Aneuploidy is toxic during mammalian development and a leading cause of pregnancy loss. Down
syndrome (DS) due to trisomy 21 is one of the few viable aneuploid syndromes, but affected individuals have
life-long problems including premature aging. Despite intense study, the reasons for aneuploidy toxicity are
still incompletely understood, presenting challenges for understanding DS. In contrast, aneuploidy is very
common in human cancers, where most tumors tolerate and may even benefit from extra chromosomes. It is
unclear how cancer cells overcome the stress of aneuploidy, because we don’t fully understand how
aneuploidy affects cells in the first place. This proposal will utilize an extremely powerful and unique system to
study the consequence of aneuploidy in an important model system, wild strains of budding yeast
Saccharomyces cerevisiae. Yeast is a powerful model for dissecting cellular biology, because many of the
mechanisms and defense strategies are conserved in humans. We recently made an exciting discovery that
chromosome duplication in healthy yeast strains disrupts nutrient responses and quiescence, a
conserved cellular program important for growth control and cell maintenance and renewal. Strains of multiple
genetic background and carrying different chromosome amplifications display shared phenotypes, including
incomplete cell-cycle arrest upon nutrient depletion, metabolic aberrations, defects in quiescence-induced
silencing, and ultimately reduced chronological life span. This is remarkable, because defects in similar
markers of quiescence are seen in both DS and many cancers – if disruption of quiescence is a conserved
response to aneuploidy, it could have transformative impacts for future studies. This grant will elucidate how
aneuploidy disrupts quiescence in an important eukaryotic model system. Aim 1 will use dynamic
transcriptomics and single-cell microscopy to characterize the temporal order of defects, test several initial
hypotheses, and implicate upstream regulators. It will also distinguish common versus chromosome-specific
effects. Aim 2 will use a barcoded plasmid over-expression library to identify genes that complement
aneuploid defects along the progression to quiescence. Integrating Aim 1 and 2 results will define a temporal
map of genes and processes defective in aneuploid yeast strains and involved in quiescence. It will also point
to the upstream defect(s) directly caused by chromosome duplication, whose further study will expand our
understanding of aneuplodiy Aim 3 will use genomic, proteomic, single-cell and single-molecule analysis to
define and characterize the “Ssd1 Q granule”, a phase separated granule containing the RNA-binding protein
Ssd1, which we previously showed is fundamental for aneuploidy tolerance in healthy yeast. Since many
mechanisms in yeast are conserved in higher organisms including humans, this project will expand our basic
understand of aneuploidy and have far-reaching impact relevant for multiple human diseases.

Public health relevance
NARRATIVE Aneuploidy plays a major role in human health, causing debilitating developmental disorders, enabling cancer evolution, and supporting drug resistance in human pathogens. This project will study how aneuploidy inhibits quiescence, a fundamental cellular state that is important for growth control, stem cell function, and tissue renewal.